Multi-level factors affecting postpartum sterilization

Title: Deliberative Bioethics to Inform Policy Surrounding the Medicaid Sterilization Waiting Period
ABSTRACT
Approximately 30-50% of patients with Medicaid requesting sterilization for contraception after delivery do not
obtain their desired surgery. Disparities in fulfilment of sterilization requests have been linked to the federal
Medicaid sterilization policy, which does not apply to patients with private insurance. This policy requires a 30-
day waiting period between when a specific consent form is signed and when sterilization can occur. However,
the bioethical considerations of the 30-day waiting period in the Medicaid sterilization policy are
complex. While data exist regarding the barriers to autonomously-desired care presented by the policy, less is
known regarding the present-day need for the historical basis for the policy’s inception – to protect against
coercion. Ongoing disparities in maternal health are attributed to structural racism, implicit bias, and social
determinants of health factors, but little is known regarding the patient viewpoint on how to achieve this
necessary balance between ensuring women covered by Medicaid, like women with other insurance, have
their autonomous decisions for sterilization respected, while ensuring freedom from coercion or undue
pressure – thus representing a critical knowledge gap. While our parent R01 (1R01HD098127H)
characterizes the multi-level barriers to equitable postpartum sterilization – this Administrative Supplement’s
overall objective, extends these efforts to better understand the goals and priorities of patients themselves
regarding revision of the 30-day Medicaid sterilization waiting period. This objective is directly responsive to
the NOSI as it has tremendous potential to exert an influence on bioethics-related policy and provide evidence
to inform future policy directions; addresses a persistent, compelling bioethics question about reproductive
decision making; and engages communities as partners in the research and, in so doing, sustains and adds
capacity for community-partnered bioethics research. Leveraging our expertise in bioethics and long-standing
community-academic partnerships, we have the infrastructure to rapidly meet our objective. Our Aims are to 1)
Engage patients and couples with Medicaid insurance in informed deliberations about the 30-day
Medicaid sterilization waiting period by conducting deliberation exercises with 10 groups of 9-15 groups of
Medicaid enrollees in Michigan who have experienced pregnancy and some that include couples. 2) Prepare
preliminary policy briefs that describe the views of patients as the stakeholders in potential Medicaid
sterilization policy revision to set the stage for future, broader community-based participatory research and
deliberative bioethics work in other states with distinct reproductive health policies as well as for eventual,
federal health policy change. Our results will provide a critical framework for long overdue, evidence-based,
and patient-centered policy recommendations to mitigate disparities surrounding sterilization.

Public health relevance
NARRATIVE The federal Medicaid sterilization policy requires a 30-day waiting period prior to sterilization and contributes, in part, to disparities in fulfillment between patients with Medicaid and private insurance – though was instituted to protect against coercion from forced sterilization, a need that continues today given structural racism and implicit bias. In this Administrative Supplement, we will utilize deliberative bioethics methodology and leverage long-standing community-academic partnerships to assess the viewpoints of patients with Medicaid and their partners regarding the utility and length of the Medicaid waiting period, given the need to balance the ethical goals of autonomy and protection from coercion. Our results will provide a critical framework for long overdue, evidence-based, and patient-centered policy recommendations to improve clinical care, advance public health, and mitigate disparities surrounding sterilization.